Mayo CCCG (Supp) - Impact of Multi-Channel Communication Campaigns on Cancer Prevention, Control and Survivorship (CaPCaS) in Black, Hispanic, Rural, and Sexual and Gender Minority Populations

ABSTRACT
This application is being submitted by the Mayo Clinic Comprehensive Cancer Center (MCCCC) to extend the
period of support for the P30 Administrative Supplement for Multi-Channel Communication Campaigns for
Improvements in Cancer Education and Outcomes (MICEO) in Underserved Populations. The MICEO program
will continue to be coordinated by the MCCCC Community Outreach & Engagement (COE) Office and Programs
in three MCCCC catchment areas (CAs): Arizona (AZ), Florida (FL), and the Midwest/Mayo Clinic Health
Systems (MCHS). The MICEO extension builds on the significant progress made through the initial MICEO
funding period. As of June 2024, our reach includes 100+ Hispanic adults in Arizona (AZ) CA, 500+ Black men
in Florida (FL) CA, and 100+ rural adults in the Midwest/MCHS CA. We developed and published the Cancer
Advocacy Handbook in both English and Spanish, with a total of 25 community health educators (CHEs) trained.
Additionally, 25 advocates from other Cancer Centers were trained during the Science of COE Conference, co-
organized by the MCCCC. Focusing on colorectal, liver, lung, and prostate cancers, multi-channel
communication activities were provided to at least 1,000+ general population aged 30 years and above across
the cancer care continuum. The distribution channels employed included print media, virtual tools (including the
Mayo Clinic Connect platform), and both virtual and hybrid events and meetings (cancer conversations), as well
as interpersonal communications (Health Fairs, Farmers Markets, Churches). The primary goal of the initial
(ongoing) supplement was to assess the impact of multi-channel communication campaigns targeting Black,
Hispanic, and Rural populations on cancer prevention, control, and survivorship (CaPCaS). The proposed
supplement extension project will continue to focus on Track 2, targeting the general population aged 30 years
and above. Specifically, the extension will continue efforts for the implementation, sustainability, and
evaluation of the MICEO initiatives across the MCCCC enterprise focusing on: Black men (prostate cancer),
Hispanic adults (colorectal and liver cancers), rural-residing adults (lung and colorectal cancers), and expansion
to include Sexual and Gender Minority health. This extension will enable us to further assess the impact of multi-
channel communication campaigns targeting Black, Hispanic, Rural, and Sexual and Gender Minority
populations on cancer prevention, control, and survivorship (CaPCaS). The specific aims of this extension are
to: (1) expand the implementation of culturally tailored multi-channel communication campaigns for targeted
populations enterprise-wide; (2) foster continuous improvement of MICEO activities based on comprehensive
evaluations focused on assessing the effectiveness of the campaigns; and (3) foster the dissemination,
replicability and sustainability of the MCCCC MICEO initiatives through community and partnership
engagements of local organizations, faith-based organizations. healthcare providers, and other educational
institutions.

Public health relevance
PROJECT NARRATIVE This application is being submitted by the Mayo Clinic Comprehensive Cancer Center (MCCCC) in response to the request for an extension of the “Administrative Supplements for the NCI P30 Cancer Center Support Grants for Multi-Channel Communication Campaigns”. The primary goal of the extension will continue efforts for the implementation, sustainability, and evaluation of the MICEO initiatives across the MCCCC enterprise focusing on: Black men (prostate cancer), Hispanic adults (colorectal and liver cancers), rural-residing adults (lung and colorectal cancers), and expansion to include Sexual and Gender Minority health. This extension will enable us to further our assessment of the impact of multi-channel communication campaigns targeting Black, Hispanic, Rural and sexual and gender minority populations on cancer prevention, control, and survivorship (CaPCaS).